Genetic screen to define the regulation of beta-hemolysin toxin expression in Streptococcus agalactiae

Group B Streptococcus (GBS) is a normal constituent of the intestinal and vaginal flora
in 15–30% of healthy adults. The bacterium can, however, cause infections in elderly and
immunocompromised patients, and pregnant women, and is the main cause of fatal invasive
disease in newborns. GBS translocation through epithelial, endothelial, and placental barriers is
facilitated by a pore-forming toxin β-hemolysin, also known as the β-hemolytic pigmented lipid
or granadaene. To identify factors involved in the regulation of β-hemolysin expression we
developed new peptide-free culture media for screening of a transposon mutant library of GBS
CJB111. The pilot screens identified nine novel genetic loci associated with positive and
negative modulation of β-hemolysin expression. Based on preliminary findings, we hypothesize
that GBS possesses a regulatory mechanism that tailors β-hemolysin expression to the
environment. To unravel the mechanism, we will employ transposon mutant library screening,
RNA-seq and metabolomics analyses, isolation, and de novo sequence determination of
secreted peptide-based repressors. The results of this exploratory work have the potential to
lead to the development of a novel inhibitor of the invasion state of GBS.

Public health relevance
Streptococcus agalactiae is the leading cause of neonatal sepsis and meningitis and an important pathogen in pregnant women and elderly patients. The proposed research has a potential to lead to the development of a novel drug selectively repressing the invasion state of Streptococcus agalactiae.